BAK Autoactivation in Hematological Malignancies

ABSTRACT
The mitochondrial apoptotic pathway plays a critical role in the response to various cellular stresses, including
targeted anticancer therapies. This pathway is regulated by interactions between various members of the BCL2
family of proteins. In particular, BAX and BAK play an indispensible role in this pathway by permeabilizing the
mitochondrial outer membrane (MOM). While BAX plays a predominant role in epithelial tissues, especially in
postnatal life, BAK is particularly abundant in normal white blood cells, leukemia cell lines, and clinical leukemia
specimens. Our previous studies have demonstrated that BAK activation is initiated by two distinct processes:
i) Transient binding of BH3-only members of the BCL2 family in response to certain stimuli (e.g., transient binding
of NOXA, which is upregulated in response to the NEDD8 activating enzyme inhibitor pevonedistat), and
ii) concentration-dependent BAK autoactivation, a process we initially described. Once activated, BAK forms
multimers that permeabilize the MOM. Our recent studies indicate that this MOM permeabilization involves the
action of a C-terminal lipid binding domain that is externalized upon BAK activation and interacts with the MOM
lipid cardiolipin. Counterbalancing this pro-apoptotic effect, however, BAK can be bound and neutralized by anti-
apoptotic BCL2 paralogs in lymphohematopoietic cell lines and primary acute myeloid leukemia (AML)
specimens. Importantly, the response of these cells to BH3 mimetics, proapoptotic small molecules that
selectively bind and neutralize BCL2, BCLXL and/or MCL1, reflects which of the anti-apoptotic BCL2 family
member(s) constitutively bind BAK. Collectively, these observations lead to the hypothesis that AMLs with
higher BAK levels will harbor more constitutively activated BAK and will be particularly sensitive to BH3
mimetics as well as targeted therapies that activate BH3-only proteins. We now propose three aims that
will test this hypothesis and provide additional insight into the action of BAK in AML during anti-leukemic therapy.
First, we will assess the mechanisms responsible for high BAK expression in some AMLs but not others because
high BAK expression contributes to BAK autoactivation. Second, we will determine the biochemical basis for
BAK autoactivation and subsequent restraint by anti-apoptotic BCL2 family members because this partially-
activated-and-then-restrained BAK is the species poised to kill leukemia cells upon exposure to BH3 mimetics
and targeted therapies that upregulate BH3-only proteins. Third, we will assess the relationship between high
BAK expression, BAK restraint by various anti-apoptotic BCL2 family members, and response of clinical AML to
a novel pevonedistat-containing combination undergoing early phase clinical testing, thereby assessing the
potential importance of constitutive BAK activation in the clinical setting. These studies, which build on our recent
advances in understanding the action of BAK at the molecular level, are collectively designed to enhance current
understanding of BCL2 family biology and simultaneously provide new insight into a potentially important
determinant of AML sensitivity in the clinic.

Public health relevance
PROJECT NARRATIVE Members of the BCL2 protein family regulate life/death decisions by modulating mitochondrial outer membrane permeability. Our previous results have demonstrated that the pro-apoptotic family member BAK is constitutively activated in a subset of acute myeloid leukemia (AML) samples as well as leukemia and lymphoma cell lines, priming them to respond to certain treatments. With an eye toward improving AML therapy, this project focuses on i) understanding the cellular and biochemical bases for this constitutive BAK activation and ii) determining the implications of constitutive BAK activation for respose to AML treatment in the clinic, using as an example the response to a novel regimen of targeted agents that is currently being developed for use in AML.